Administrative

SUMMARY/ABSTRACT - ADMINISTRATIVE CORE
The program is named the Center for Collaborative Research in Health Disparities, signaling an
emphasis on extensive and intensive research collaborations and partnerships, including the RCMI
Coordinating Center (RCMI-CC), the National Research Mentoring Network (NRMN) and community
organizations. The Administrative Core will enhance and maintain a cohesive and integrated program
and will also foster an inclusive governance structure that includes the PI, the Core Directors and
Advisory Committee members, as well as the administrative and technical staff. This structure will be
sustained by an operational meeting structure that will allow effective communication at different program
levels. This is designed to ensure collaboration among all cores and minimize the possible effect of
physical separation and/or dissimilar areas of expertise. Meetings will be complemented by activities
utilizing web-based network tools to facilitate and maximize communications. One of the major goals of
the Administrative Core is the development and coordination of strong and targeted Career Enhancement
Activities. This effort will include, among others, (1) a one-to-one mentoring program to assist new and
early-career investigators (ECIs) through career planning, development and grantsmanship (2) a course
in the skills necessary to be successful in a research career, including discussions of bioethical issues
relevant to research, and (3) a seminar series focusing on the protection and commercialization of
intellectual property, especially in a collaborative multidisciplinary setting. These activities will be
performed in coordination with other mentoring activities being conducted at the MSC or offered by the
NRMN, to avoid duplication of efforts and leveraged resources. The required Evaluation component will
monitor the overall progress of the RCMI-CCRHD at the University of Puerto Rico Medical Sciences
Campus, toward achieving its goal of enhancing the research capacity and infrastructure of the institution,
with an emphasis on innovative, collaborative research aimed at reducing health disparities that affect the
Puerto Rican population. The evaluation will focus on assessing the implementation of activities aimed at
strengthening the Center’s five cores (process) and assessing the extent to which the Center is achieving
its short-term and long-term goals (outcomes). The key activities and program goals will be incorporated
into a Conceptual Framework. Data will be collected for each of the variables in the framework, and logic
models for each core will be developed. Milestones will be used to measure the success of the overall
program. These administrative activities are expected to support the development of Early-Career
Investigators and promote minority health and health disparities research.

Public health relevance
Project Narrative – Administrative Core As per RFA MD-22-002 instructions, this section is only required in the Overall Section.